Multi-Scale Computational Modeling Core (MCM)

SUMMARY
The Multi-scale Computational Modeling (MCM) Core will continue to provide essential expertise and
infrastructure in the area of multi-scale and multi-discipline computational modeling of bioengineering and
biomedical problems, with a new addition of Artificial Intelligence/Machine Learning (AI/ML) capacities for big
data driven modeling in the COBRE Phase II. Key to Virtual Human Trials, the organizing concept of SC-TRIMH,
is to develop predictive multi-scale models of the human body for assessing new interventions, devices, and
therapeutics. As its main mission, this core will support our SC-TRIMH investigators in all their computation and
simulation needs at molecular, cellular, tissue, body, and population levels toward improving musculoskeletal
health. Additionally, it will provide mentoring and strategic planning to all SC-TRIMH investigators and associates,
especially those who do not have primary expertise in the areas of multi-scale computational modeling, AI/ML,
or using cluster parallel computing to maximize their computational outcome. Thus, investigators will be advised
on best approaches, model building strategies, and software settings to take full advantage of Clemson
University's cluster parallel computing capabilities and extensive AI/ML research capacity. Furthermore, we will
strive to build the MCM Core into the “go-to place” that facilitates comprehensive computational bioengineering
research for investigators from across South Carolina, in the southeast, the nation, and around the world.
Specifically, the MCM core will maintain and develop the most advanced software tools and packages to enable
SC-TRIMH investigators to perform computational bioengineering and biomedical modeling at molecular, cellular,
tissue, body, and population levels (Aim 1); the MCM core will tune and expand the current set of computational
tools and packages to integrate AI/ML based modeling so that they will run on Clemson's Palmetto Cluster (Aim
2); the MCM core will enhance standard and project-specific assistance and mentoring to the COBRE Research
Project Leaders (RPLs), other SC-TRIMH investigators, and their team, especially those who do not have primary
expertise in modeling of complex problems (Aim 3); the MCM core will further promote the MCM Core as a
leading resource and the “go-to place” for researchers from Clemson University, South Carolina, the southeast
region and beyond for all multi-scale and multi-discipline computational modeling of complex bioengineering and
biomedical problems at cellular, tissue, body, and population levels with special emphasis on expertise in building
patient-specific or cohort-based musculoskeletal systems (Aim 4). Since the inception of the MCM core, the
number of projects utilizing the Core has significantly increased each year. During Phase II, we will further
develop the core capacities by acquisition and development of new software tools and packages for AI/ML-based
modeling and its integration with deterministic modeling and probabilistic modeling. To nurture a musculoskeletal
research community, we will expand the current platform to enhance the interaction between the SC-TRIMH
investigators, Core Directors, and external resources relating to computational modeling.

Public health relevance
NARRATIVE The Multi-scale Computational Modeling (MCM) Core will continue to provide support for SC-TRIMH investigators toward building a patient-specific and precision-care musculoskeletal system through computer simulations at molecular, cellular, tissue, body, and population levels, with a new addition of Artificial Intelligence/Machine Learning (AI/ML) capacities for big data driven modeling in the COBRE Phase II. This core will take full advantage of the current resources and capabilities at Clemson University, which entails Clemson's powerful supercomputing capability, known as the “Palmetto Cluster” (listed on the TOP500 in the world), the well-established Multiphysics Modeling Studio, the extensive AI research capacity at Clemson, and the large amounts of patient-specific data available for model building at the PRISMA Health System.